Adipose tissue distribution determines microglial regulation of hippocampal plasticity

PROJECT SUMMARY
The ‘apple-shaped’ anatomical pattern that accompanies visceral adiposity increases dementia risk in humans,
but the 'pear-shaped' distribution that reflects subcutaneous adiposity does not predict cognitive impairment and
may be protective. Several recent studies, including from our lab, have outlined signaling cascades linking
peripheral and central inflammation in obesity in males, but vulnerability to obesity-induced metabolic pathology
is sexually dimorphic, and susceptibility to neuroinflammation follows similar patterns. Adult females exhibit
stronger innate immunity, and evidence from clinical and experimental studies suggests that this dimorphism
involves sex differences in anti-inflammatory cytokines. However, current understanding of tissue-specific anti-
inflammatory signaling remains rudimentary due to the scarcity of approaches for selective manipulation.
Moreover, regionally heterogeneous responses to dietary obesity in different brain areas remain incompletely
characterized, leaving open questions surrounding feedforward neuroimmune control versus immunological
feedback. The proposed experiments will generate a comprehensive topographical map of neuroimmune
responses to chronic overnutrition and elucidate the role of the anti-inflammatory cytokine interleukin-4 in these
effects. We will use light-inducible cre drivers and direct delivery of tamoxifen metabolites to selectively
manipulate immune cells in cerebrospinal fluid. These technically innovative approaches will be followed by
anatomical mapping of lymphocytes and myeloid cells in cleared tissues, single-cell flow cytometric analysis, or
analysis of neuronal function at the behavioral and electrophysiological level. Understanding circuit-specific
sexual dimorphisms in obesity could yield fundamental insights into the pathogenesis of neuroinflammation in
different microenvironments, and could also identify target structures for noninvasive therapeutic modulation.

Public health relevance
PROJECT NARRATIVE Males and females exhibit sexually dimorphic vulnerability to obesity-induced pathology in multiple tissues, including the brain. Our recent findings suggest that subcutaneous adipose tissue, which is more abundant in females, protects against brain inflammation and synaptic dysfunction in mice with dietary obesity. The proposed experiments manipulate subcutaneous fat and anti-inflammatory signaling between cerebrospinal fluid immune cells and parenchymal glia to elucidate the underlying mechanisms for neuroprotection. In doing so, we hope to understand why the 'apple-shaped,' but not the 'pear-shaped' body fat distribution predicts dementia risk in humans, with the long-term goal of identifying novel risk factors for cognitive impairment.